Molecular Mechanisms of Environmental Injury

PROJECT SUMMARY
The UTMB Environmental Toxicology T32 Training Grant has been in existence since 1991. In the 31 years of
its existence, training has been provided to 103 predoctoral fellows and 37 postdoctoral fellows, including 9
physician-scientists. The 140 trainees who have completed their training typically have professional positions in
basic and applied research, biotechnology, government, teaching, risk assessment and/or practical problems of
environmental pollutant regulation and policy. Since 1991, 12 have academic faculty appointments or positions
as academic research scientists and 36 have obtained individual NIH or other fellowships, including 18 from
NIEHS. We have had significant inclusion and participation of typically 20-40% under-represented minorities and
women as T32-supported trainees, annually, since 2009. Accordingly, we are requesting an administrative bridge
supplement for continuing support of our five predoctoral fellows, currently pursuing their training in our program
to become independent and competitive scientists. Key elements in our unique climate for training are a
multiplicity of environmental-health relevant research centers and institutes: 1) the Sealy Center for
Environmental Health and Medicine (SCEHM), and other UTMB Sealy Centers, 2) the Institute for Translational
Science (ITS) with its recently renewed (2021) NIH Clinical Translational Science Award (CTSA), 3) the
collaborative NIEHS-supported Gulf Coast Center for Precision Environmental Health (GC-CPEH) between
Baylor College of Medicine, UT Houston, and UTMB (funded 2019), and 4) the new NIH-funded OneHealth
environmental health initiative at UTMB. We offer training in 4 general thematic areas where we have
experienced faculty, exemplary institutional support, and superb resources for state-of-the-art environmental and
translational research: 1) airway inflammation/obstruction pathogenesis, 2) intracellular regulation and signaling,
3) DNA damage and repair, and 4) organ pathophysiology, all with a unifying theme of oxidant injury. Over the
past 3-5 years, we have developed 6 new areas of targeted research emphases: 1) NIH CounterACT/Chemical
Countermeasures Research Program, 2) drug discovery & development, 3) biomedical imaging & bioengineering,
4) neurological & developmental toxicology, 5) OneHealth environmental exposure & disease mitigation, and 6)
innovation & entrepreneurship. Our didactic graduate curriculum builds from an interdisciplinary common first
year, toward advanced courses in molecular toxicology, pathology, proteomics/bioinformatics, and specialized
topic short courses. Identity and community within our training program is established with structured activities
such as specialized toxicology courses, journal club, and regional and national toxicology meeting attendance.
Professional development in teaching, communication, mentoring, and academic responsibility is fostered by
participation in our courses in which the trainees experience teaching of basic and applied toxicology principles,
our BENCH high school mentoring program, and our Near-Peer Mentoring Initiative, in conjunction with the
Individual Development Plan (IDP).

Public health relevance
PROJECT NARRATIVE Our NIEHS T32-supported Training Program in Environmental Toxicology (ETox) has been in existence at UTMB for over 30 years, and this administrative bridge supplement seeks to continue our federal support for this uniquely outstanding program, in an exemplary academic venue, having federally-funded trainers, a tradition of successful trainee placement, support from our NIH Clinical Translational Science Award (CTSA), and unparalleled institutional support for research from our Sealy Foundation and the UTMB Graduate School of Biological Sciences (GSBS). Four training areas of institutional strength in toxicology-relevant areas include: 1) airway inflammation/obstruction pathogenesis, 2) intracellular regulation and signaling, 3) DNA damage and repair, and 4) organ pathophysiology, all sharing a unifying theme of oxidant injury, in which T32 fellows experience exceptional training in research, teaching, and didactic coursework. Importantly, our new emphasis within our ETox Training Program has been its purposeful integration with our NIH CTSA and the collaborative NIEHS P30 Gulf Coast Center for Precision Environmental Health (GC-CPEH), and our new Sealy Institute for Drug Discovery (SIDD), to provide our trainees with collaborative and translational mentoring, as well as broadened training opportunities, which are vital components of existing and developing federally-funded research initiatives, at UTMB.